Remote Data Enclave Core

Project Summary
The Remote Data Enclave (Core F) facilitates safe access to restricted-use data by CDHA’s affiliates in two
distinct ways. First, Core F supports Silo, a high-security, high-powered computation environment maintained by
the Social Science Computing Cooperative (SSCC). Second, Core F supports WiscRDC, the Federal Research
Data Center based at UW-Madison. WiscRDC allows CDHA researchers to work with sensitive data maintained
by the federal government, primarily the Census Bureau, while Silo allows CDHA researchers to work with all
other sensitive data. Together with data use agreements managed by the Social Science Research Services
(SSRS), these two enclave resources provide CDHA’s internal and external affiliates access to large-scale (often
longitudinal) datasets with complex, deeply-described phenotypes that are linked to administrative, geographic,
biological, contextual, and genetic data from a wide variety of sources.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is in the Overall section of this proposal.